BLRD Research Career Scientist Award Application

This proposal seeks to renew Research Career Scientist Award held by Dr. Subhra
Mohapatra, at the James A. Haley VA Hospital in Tampa, Florida since 2018. She is also a tenured-
full professor (part-time) at the VA-affiliated academic center- the University of South Florida. She
is the recipient of several international/national awards and recognitions including as a Fellow of
the National Academy of Inventors and a Fellow of the American Institute for Medical and Biological
Engineering. Dr. Mohapatra has been a research investigator at the VA Hospital (Medicine) since
2007 and has been continuously funded with the Merit Review Award focused on cancer, traumatic
brain injury (TBI), and COVID since 2016. She has been studying the basic molecular and
translational mechanisms underlying the inflammation in diverse acute/chronic diseases including
COVID-19, cancers, and TBI, all of which afflict VA population and contribute significantly to the
overall health of the Veterans. The main premise of her research program has been to
understand the mechanisms involved in the disease pathogenesis toward developing novel
diagnostic/prognostic and therapeutic approaches to treat them. Current and ongoing research
activities to be supported by this RCS Award focus on three areas. The first program centers on
the characterization of novel virus-neutralizing nanoparticles that may serve as prophylactic and/or
treatment for COVID-19 patients. In this proposal, these particles will be investigated for their potential
and validated in relevant human cellular and mouse models. She is collaborating with other VA
investigators in developing an additional project to develop novel siRNA-based prophylactic and
therapeutic approaches targeting viral replication and cytokine storm that follows acute SARS-
CoV-2 infection. The second research program focuses on the investigation of a novel
combinatorial therapeutic approach in a mouse model of moderate TBI that includes an intranasal
dendrimer-based nano-formulated siRNA treatment against a recently discovered target, CCL20 to
reduce inflammation, and a parallel treatment to promote neuroregeneration by therapy with
mesenchymal stem cells. In the third research program Dr. Mohapatra’s lab aims to investigate
and test a novel targeted oncolytic viro-cell therapy for lung cancer using the mesenchymal stem
cells infected by a respiratory syncytial virus infection, which is harmless for immunocompetent
individuals. This project uses a 3D multicell tumoroid in vitro and biopsy-derived cultures ex vivo,
which her lab has pioneered. Further, this project uses in vivo mouse models of lung cancer to
evaluate the safety and efficacy of oncolytic viro-cell therapy. The project to date has attracted
industry collaboration, which might lead to clinical trials. Overall, these highly innovative
approaches taken together are expected to lead to high-impact clinical diagnostics and therapies
for diverse diseases of Veterans and other Americans in need. Veterans have been
proportionately affected by the pandemic and are increasingly affected by the incidence of lung
cancers and TBI compared to the general population. With ~100 publications, 20 patents, an h-
index of 36 and an i-index of 85, Dr. Subhra Mohapatra is recognized nationally and
internationally for her contributions to the fields of research on cancer, neurodegenerative disease,
and viral infections. She has received substantial extramural research support including awards
from the NIH, ONR, Department of Veterans Affairs, and Florida Department of Health. It is
anticipated that the development of these effective therapeutics will greatly improve the quality of
Veteran’s healthcare.

Public health relevance
Dr. Subhra Mohapatra is a recognized leader in research on the molecular and cellular mechanism of Inflammation, which is the central feature of most chronic human diseases, that afflict millions of Veterans. Her major research emphasis has been on using nano- and - biotechnology-based diagnostic and therapeutic approaches to advance the treatment of diverse human diseases, which have already led to clinical studies and/or products in the marketplace. Thus, her Lab at the James A. Haley VA Hospital, Tampa has discovered a few drug targets and packaged them in nanoformulations that are expected to advance the treatment for COVID-19 virus infection-induced lung disease, traumatic brain injury and other neurocognitive diseases, and a variety of cancers including lung, breast, and colorectal cancers, some of which are under clinical evaluation for efficacy.